Data Aggregation, Standardization and Sharing

ABSTRACT: This Conte Center proposal unites collaborators from 15 different institutions with the overarching
goal to understand the role of slow network fluctuation in the brain. Across Center projects, experimental data
will be collected on humans and non-human primates (NHP). The Data Aggregation, Standardization, and
Sharing Core (DASS-C; Core C) is the component of this center through which the overall management and
sharing of experimental and processed data will be conducted. Dr. Alexandre Franco will serve as the project
leader of the DASS-C and will be based at the Nathan Kline Institute (NKI). We will support the research efforts
within our team project, by facilitating the standardization and sharing of data across projects, member
laboratories, and the scientific community at large. We will follow the FAIR (findable, accessible, interoperable,
and reusable) guiding principles for scientific data management and sharing. The DASS-C will also perform
quality control and minimal preprocessing of the data and support the computational needs across P1-4 and
Core B (Multimodal Data Analysis & Integration Core).Thus, the overarching goal of the DASS-C is to
maximize the scientific value of the data produced by the center and to minimize the difficulty in accessing it
among center researchers and the scientific community. We have four Specific Aims. 1) - Guide and support
the development and adoption of community data standards. 2) - Provide a data management platform to enable
data aggregation and sharing across projects. 3) - Perform quality control and minimal preprocessing of data.
4) - Facilitate the dissemination of datasets and the reproducibility of analyses.